POPULATION HEALTH RESEARCH SUPPORT

The Division of Intramural Population Health Research (DIPHR) is an intramural research division at the Eunice Kennedy Shriver National Institute of Child Health and Human Development (NICHD) whose mission is to improve population health across the life course by maximizing health and preventing disease [http://www.nichd.nih.gov/about/org/DIPHR/Pages/default.aspx]. The Division comprises the Office of the Director along with three research branches: Biostatistics and Bioinformatics, Epidemiology, and Health Behavior. As an intramural research entity, the Division designs and conducts innovative, high-risk research aimed at answering critical data gaps regarding human fecundity, reproduction and development; pregnancy and delivery, including adverse pregnancy outcomes; offspring health, growth and development from birth to adulthood, and adolescent behavior. In addition, the Division conducts original methodologic research aimed at developing novel statistical tools for analytic purposes. The Division's research focuses on various population subgroups including couples or individuals of reproductive age, pregnant women, infants, children, and adolescents. Increasingly, research is designed to assess the early origins of health and disease underscoring the need for the development of accurate methods for measuring environmental (non-genetic) exposures during sensitive windows of human development in the context of genetics, with the overarching goal of identifying population level interventions for maximizing health across the lifespan. The multi-faceted nature of the Division's research includes normative, etiologic and interventional research, examples which follow: 1) studies aimed at defining 'normal' or recruiting generally healthy participants include the NICHD Fetal Growth Studies and BioCycle Study, and 2) studies aimed at determining the relation between environmental (non-genetic) exposures (e.g., Upstate KIDS Study, ENDO Study and LIFE Study), 3) bio-behaviors (e.g., Naturalistic Teen Driving Studies and NEXT Study), and 4) genes (e.g., Diabetes and Women's Health and Genetic Determinants of Birth Defects) and a spectrum of outcomes. In addition, the Division conducts interventional research involving but not restricted to families (e.g., CHEF Trial and FMOD Trial) and clinical populations (e.g., EAGeR Trial and FAZST Trial). The Division also conducts perinatal epidemiologic studies involving detailed collection of information from medical records (e.g. Consortium on Safe Labor and NICHD Consecutive Pregnancies Study). Examples of past sampling frameworks utilized by the Division typically include population-based strategies (e.g., random samples of well-defined registries, marketing databases), clinically based sampling (e.g., administrative and clinic records, surgical schedules), schools, and convenience-based sampling with strict eligibility criteria for trials from clinical sites, schools and the general public. Increasingly, the Division recognizes the utility of leveraging existing cohorts for life course approaches to health and disease (e.g., Diabetes &Women's Health study), and continues to explore new avenues for sampling population subgroups including the use of social media and web-based venues. Irrespective of the final sampling framework, the Division strives to design research and implement sampling strategies that characterize their respective referent populations to maximize the eventual translation of findings. Division investigators are responsible for designing original research to answer critical and pressing data gaps within the mission. Investigators in the Biostatistics and Bioinformatics Branch lead the development of the analytic plan for Division research. Thus, the Division's research is innovative in design with the upside of positively impacting population health through the translation of findings.